Investigating R-pyocins as a therapeutic approach to treat high-risk, multidrug-resistant Pseudomonas aeruginosa wound infections

Project Summary
Pseudomonas aeruginosa (Pa) is a versatile human pathogen responsible for a range of acute and chronic
infections, notably those stemming from traumatic injuries, burns, chronic wounds and respiratory diseases
such as Cystic Fibrosis. The prevalence of high-risk multidrug-resistant (MDR) and extensively drug-resistant
(XDR) Pa has been rising over the past decade, causing significant concern due to limited treatment options
and increased morbidity and mortality. Current therapeutic development approaches often rely on studies
using laboratory strains, which may not accurately represent the efficacy against high-risk clinical isolates. The
goal of the proposed work is to investigate the use of R-pyocins, narrow-spectrum antimicrobial proteins
produced by Pa, as a novel therapeutic approach to treat wound infections caused by high-risk, antibiotic-
resistant Pa strains by: (i) determining R-pyocin diversity and antimicrobial efficacy against high-risk
MDR/XDR Pa strains, and (ii) investigating the reversal of antibiotic resistance in MDR/XDR Pa strains
using R-pyocins as a selective pressure. The hypotheses are that (i) certain R-pyocin variants will
demonstrate superior bactericidal activity against high-risk Pa strains in both in vitro and in vivo settings,
potentially offering a novel therapeutic approach for treating resistant Pa infections, (ii) R-pyocin exposure will
promote mutations or deletions in the galU gene, which is essential for the synthesis of a complete
lipopolysaccharide (LPS) core and O-antigen, and that (iii) these mutations may also affect nearby genes,
including the mexXY efflux pump genes, leading to increased susceptibility to conventional antibiotics. The first
aim will involve identifying R-pyocin types in a biobank of 100 high-risk Pa strains using a bioinformatics tool
called PyocinTyper, extracting and purifying R-pyocins from selected strains, and assessing their bactericidal
activity through in vitro assays and in a murine chronic wound model. The second aim will involve exposing
MDR/XDR Pa strains to increasing concentrations of R-pyocins, screening for surviving brown phenotype
strains, characterizing the genetic changes in these mutants, and evaluating their antibiotic susceptibility
profiles and efflux activity in vitro and in vivo. The findings of this project will provide new insights into the
therapeutic applications of R-pyocins and potential strategies to combat antibiotic-resistant pathogens in
human infections, addressing a critical healthcare challenge and informing the development of novel
antimicrobial therapies.

Public health relevance
Project Narrative Multidrug-resistant (MDR) and extensively drug-resistant (XDR) Pseudomonas aeruginosa (Pa) strains are a significant healthcare burden, particularly in the context of chronic wound infections. This project aims to investigate the use of R-pyocins, narrow-spectrum antimicrobial proteins produced by Pa, as a novel therapeutic approach to treat infections caused by high-risk, antibiotic-resistant Pa strains and to explore their potential to reverse antibiotic resistance. The findings of this project will provide new insights into the therapeutic applications of R-pyocins and potential strategies to combat antibiotic-resistant pathogens in human infections, addressing a critical healthcare challenge and informing the development of novel antimicrobial therapies.